REVACCINATION OF NONRESPONDERS TO HEPATITIS B VACCINE WITH HBMP OR RECOMBIVAX HB

Comparison of 10 mcg. dose of Hepatitis B Mixed Particle Vaccine with 40 mc dose of Recombivax HB to minimize side effects in nonresponders.